Proteomic Signatures of Delirium and Longterm Cognitive Decline in Older Cardiac Surgical Patients

Project Summary
Postoperative delirium following cardiac surgery is characterized by sudden onset confusion and inattention. It
incurs substantial costs and can lead to long-term cognitive decline, including Alzheimer’s disease and Related
Dementias (AD/ADRD). Enhancing our ability to identify at-risk patients before surgery and implementing
targeted interventions based on underling pathophysiology is important. In our DexAcet trial, which demonstrated
the effectiveness of intravenous acetaminophen in reducing postoperative delirium after cardiac surgery (JAMA
2019), we conducted a systematic analysis of plasma samples collected at baseline and on postoperative day
2. Utilizing the SomaScan platform v 3.2 to analyze 1305 proteins, we developed a multivariable risk model for
predicting preoperative delirium, identifying three novel proteins (TIMP1, ANGPT2, and CCL5), and highlighting
older age and female gender as additional risk factors. These proteins indicate disruptions in immune function,
inflammatory response, and neovascularization regulation. Furthermore, insights from proteomics research in
the Sages I & II cohorts suggest, a systemic pre-inflammatory state predisposes to a hyperactive inflammatory
response to major surgery, resulting in delirium in those with vulnerable brains. The DexAcet trail led to a
successful NIA funded PANDORA trial to examine the impact of scheduled 6-hourly intravenous
acetaminophen over 48 hours in 900 cardiac surgical patients (760 recruited, May 2024 from 12 centers).
Leveraging on the banked plasma specimens from this ongoing trial, we will use a state-of-the-art
SomaScan v5.0 proteomics platform that measures 11,000 proteins to derive (N=300, placebo group) and
validate (N=remaining 150 placebo group patients) a delirium protein signature for cardiac surgery (Aim 1a).
The SomaScan-derived top 10 proteins will be independently validated with standard antibody-based methods
(Ella) in all 450 placebo group patients (Aim1c). This model will then be probed with the acetaminophen group
(N=450, Aim1b). We will combine proteins from the AD/ADRD and aging proteomic signatures, along with
additional proteins from the 11,000 protein SomaScan v5.0 covering many biological pathways, for a deep
etiopathological characterization of the plasma proteome for delirium and 12-month cognitive decline in the
Pandora cohort (Aim 2). Furthermore, leveraging data from the NIA-funded Sages I (N=560) & II (N=420)
cohorts, we will independently validate the risk model developed in Aim 1 (Aim 3a) and explore similarities and
differences in delirium mechanisms between cardiac and non-cardiac surgeries (Aim 3b). This
comprehensive approach aims to provide new insights into the molecular mechanisms underlying delirium
risk, pathogenesis, and its association with 12-month cognitive decline. Ultimately, the project seeks to
develop accurate blood-based biomarkers for preoperative delirium risk prediction, prognostication of
cognitive decline following delirium, and lay the groundwork for targeted interventions to improve
outcomes in older adults at risk of delirium following cardiac surgery.

Public health relevance
Project Narrative Delirium (sudden onset confusion, inattention, and altered mental state), a significant complication following heart surgery in older adults, is costly and leads to long-term complications such as Alzheimer’s disease. Leveraging on the banked plasma specimens from the ongoing Pandora trial, our project will use proteomics, a technique measuring levels of 11000 proteins in blood, to develop a panel of proteins that predict the risk of developing delirium and 12-month cognitive decline and independently validate them in the Pandora cohort and Sages I & II cohorts. We will decipher the mechanisms behind the efficacy of acetaminophen, if it works, and ascertain the commonalities and differences between cardiac and non-cardiac surgical delirium mechanisms.